Quantitative Bioscience Core

PROJECT SUMMARY/ABSTRACT
Core 1: Quantitative Bioscience Core
The main goal of the Quantitative Bioscience Core is to provide a centralized service for biostatistics and
bioinformatics needs of the program. The core will work closely with all three projects and the HPM Core to
provide experimental design and multi-level omics data analysis to enable in-depth understanding of
microenvironment alterations associated with adenoma progression and malignant transformation. The core will
provide quality control for all animal and clinical studies, cutting edge pipelines and methods for multi-omics data
analysis, and develop and evaluate novel methods for integrative single-cell and spatial transcriptomics analysis.